Core B: Biospecimen Repository

PROJECT SUMMARY/ABSTRACT
The Biospecimen Repository Core is designed to provide support to the basic translational research efforts of
the SPORE. The Core will continue to play a central role in collecting, annotating, storing, distributing, and
tracking prostate cancer tissue and blood biospecimens from patients enrolled in research protocols. Detailed
biospecimen annotation, including documentation of pre-analytic processing variables, pathology findings, and
patient clinical history information will be recorded in robust relational databases. We will conduct rigorous data
quality assurance and quality control measures, and standardized longitudinal follow-up of all consented
patients with materials in the prostate biospecimen repository. The Core will provide SPORE investigators with
expert histopathological evaluation of tumor samples both from patients enrolled on research protocols and
from xenograft models. The Core will also provide assistance in performing and interpreting
immunohistochemical and in situ hybridization assays, in selecting tissue for microdissection and construction
of arrays, and in collaborating with project leaders and the directors of the Biomarkers Core and the
Biostatistics and Bioinformatics Core. This project will maintain and expand a model prostate cancer resource
to collect, annotate, store, and distribute biospecimens for translational prostate cancer research; perform
systematic pathologic evaluation of all human and animal tissue samples and preparation of appropriate
tissues for use by SPORE investigators; and collect, process, annotate, store, and distribute blood specimens
under Clinical Laboratory Improvement Amendments (CLIA)–regulatory conditions for use by SPORE
investigators.

Public health relevance
PROJECT NARRATIVE Through the work of the MSK SPORE in Prostate Cancer, supported by the Biospecimen Repository Core, we hope to increase our understanding of the clinical, biologic, and genetic basis of prostate cancer to improve patient outcomes; to facilitate a range of scientific activities that could lead to new genomic- and proteomic- based interventions for cancer, including target identification and validation; and to develop new biomarkers, diagnostics, and pharmacogenomic analyses.